Diverse & Equitable Student Inclusion in Research for future VETerinarians (DESIRe-Vet)

1 Project Summary/Abstract
2 The main objective of the DESIRe-VET program (Diverse & Equitable Student Inclusion in
3 Research for future VETerinarians) program is to inspire a diverse group of qualified veterinary
4 students to pursue careers in biomedical research. The rationale stems from societal needs to
5 diversify the workforce engaged in biomedical research and benefit from the unique skillset of
6 veterinarians. The program design targets factors influencing career paths, such as active
7 participation in research and social cognitive career theory. The DESIRe-VET program
8 distinguishes itself by its targeted applicants, distributed research environment, team
9 mentoring, scope of research, and hybrid delivery of didactic content. The 11 week-long
10 program leverages established relationships between Western University of Health Sciences
11 (WUHS), the Beckman Research Institute of City of Hope, and the School of Medicine at the
12 University of California San Diego.
13 The training will manly consist of hands-on experience in high-priority areas of biomedical
14 research. The initial pool of experienced mentors in this program have active research on
15 chronic and / or inflammatory diseases, with an emphasis on their immunobiology. In addition
16 to research mentors, scholars will be supported by coaches with multicultural competence and
17 knowledge of educational and non-academic experiences of under-represented minorities.
18 Finally, the program will include formal and informal peer mentoring activities. Group training
19 will focus mainly on responsible conduct of research, scientific rigor, reproducibility, career
20 opportunities in biomedical research, dissemination of results, (mini-
21 symposium), advances in biomedical research (mini-symposium), and dissemination of results.
22 The format will include seminars, group discussions, panels, case-based sessions, and
23 workshops, available remotely or in-person. Mandatory in-person activities will include
24 orientation, social events, and two field trips. The DESIRe-VET program will serve a cadre of 5
25 students within the first two years of the WUHS-veterinary curriculum each year, including a
26 majority URM students.
27 At the end of this program, we expect scholars to follow responsible conduct in research;
28 provide a critical appraisal of methods used in their project to ensure scientific rigor and
29 reproducibility; be competent in basic technical skills relevant to their project; describe selected
30 research priorities, ; know career pathways available to
31 veterinarians in biomedical research; and have gained resilience and confidence in their ability
32 to engage in research.
33 The short-term outcomes of the program include poster
34 presentation at the National Veterinary Scientific Symposium and a podium presentation within
35 12 months of the program.
36
37
38
39
31
animal models
including relevant animal models
We expect most scholars to participate in the “veterinary scientist track”
available to them until graduation.
In the long-term, we expect that DESIRe-VET alumni will show
higher productivity and retention in research than alumni of our current summer training and
matched students who did not participate in research.

Public health relevance
The DESIRe-VET program will engage diverse groups of veterinary students in biomedical research conducted at partnering institutions. Supported by research mentors, coaches and peers, scholars will learn how to conduct good research, work on their own project and feel like “scientists”. This experience is intended to inspire them to pursue a career in biomedical research and bring diversity to the field.